Development and Maintenance of the Animal Feed Regulatory Program Standards

The mission of the Office of Indiana State Chemist (OISC) is to protect the public consumer, livestock and
pets, and manufacturers/producers from: Falsely represented and otherwise misrepresented feed, fertilizer,
seed, and pesticide products in the marketplace; misuse of feed, fertilizer, seed or pesticides such that these
may cause disease or harm to persons or animals, or unacceptably disturb the environment. This mission is
accomplished by assuring truth in labeling for feed, fertilizer, seed, and pesticide products offered in Indiana
commerce; by requiring training of identified users and handlers of these materials; and by regulating products
and persons to gain compliance with Indiana and federal laws that have been assigned to OISC. OISC may
involve legal remedies (fines and penalties) 1) to secure an expectation of safety in the purchase of feed,
fertilizer, seed, and pesticide products marketed in Indiana for consumers, and therein, provide protection for
pets or livestock; 2) to ensure responsible use of these same products through labeling and educating the user
to gain compliance; and 3) to actively support an integrated food safety system and contribute to improving the
Indiana environment. The primary objective of our proposal is to further develop, implement, and sustain
Indiana's best practices for a quality regulatory program to enhance animal feed and food safety. This would
entail the strengthening of interagency collaboration, cooperation, and communication; achievement and
sustainment of compliance with the Animal Feed Regulatory Program Standards (AFRPS); enhancement of
coordination and interactions with the U.S. Food and Drug Administration (FDA) and other states' feed
inspection programs. Under this proposal we are requesting $300,000 annually in grant funds for the next five
years. Grant funds will be used to augment current animal feed inspection program capabilities and provide the
necessary infrastructure to continue further development and sustainment of AFRPS. Time of one full-time
equivalent (FTE) employee, travel necessary for collaboration and innovation, and some laboratory equipment
and supplies will enable enhancements to the program's ability to conduct high-quality inspections and
investigations to reduce the incidence of animal feed contamination and ultimately foodborne illness associated
adulterated animal feed material/supply facilities.

Public health relevance
Development and Maintenance of the Animal Feed Regulatory Program Standards (AFRPS) (U18) PAR-20- 132 will enable the Office of Indiana State Chemist (OISC) to develop a risk-based feed safety program, establish a uniform foundation for the design, management, measurement, and improvement of the program and enhance the programmatic objective to protect public health through the regulation of animal feed. Through the implementation of the AFRPS, OISC will improve upon directing regulatory activities toward reducing foodborne illness attributed to feed safety hazards in animal feed materials and feed supply facilities.